HYPERPHENYLALANINEMIA AND PHENYLKETONURIA

PKU patients are characterized according to growth, developmental, psychological, nutritional and family functioning parameters, and this information is evaluated with respect to phenylalanine and tyrosine levels.